Administrative Core

Abstract
The purpose of the Administrative Core is to provide the leadership and administrative management for the
proposed multidisciplinary P50 SPORE aimed at capitalizing on the infrastructure at the University of Hawai`i
Cancer Center (UHCC) and the racial/ethnic diversity of its catchment area to conduct translational research
addressing the racial/ethnic differences in cancer risks and outcomes that exist in Hawai`i and the Pacific. The
Administrative Core will build upon a number of UHCC resources, both administrative and scientific, to foster the
implementation and coordination of the research in this P50. This Core will also closely coordinate the P50
resource-building and career-development activities with those implemented by UHCC, so greater efficiency is
achieved at the institutional level. Thus, this Core serves major administrative and integrative functions for the
grant. The P50 will rely on an Internal Advisory Committee (IAC), consisting of key senior basic and clinical
researchers on cancer disparities, to receive input on research opportunities and to facilitate coordination with
potentially synergistic local initiatives. The program will also benefit from the input of a Community Advisory
Board (CAB) composed of community leaders and patient advocates with experience in cancer disparities and/or
survivorship, and who will advise on the responsiveness of our activities to community needs and expectations.
Program evaluation will heavily rely on the input of an External Advisory Board (EAB) composed of outside
investigators who are leaders in SPOREs and/or cancer health disparities research and a nationally-recognized
patient advocate. Specific Aim 1 will be to provide the overall scientific and administrative coordination and joint
leadership for the P50 grant. Specific Aim 2 will be to coordinate and integrate the P50 activities with those of
UHCC. Specific Aim 3 will be to plan and evaluate current and future translational cancer disparities research
as part of the P50 SPORE program. The Administrative Core will play an essential role in supporting the research
program proposed in the P50. We believe that the skills and experience of each Core Co-Leader and the proven
approaches described in this section will provide both the foundation and the building blocks to achieve our
goals.